Examining the physical toll of marginalizing experiences in emerging adulthood and exploring resilience possibilities

PROJECT SUMMARY
Scholars have called for greater attention to the etiologic role of social identity-related stressors in the
creation and maintenance of health disparities. In this domain, a focus on emerging and early adulthood is
warranted given that identity-related concerns peak during this developmental period. Among
underrepresented college students attending elite predominantly white institutions, the confluence of
heightened needs for identity supports and influx of marginalizing experiences may yield the perfect storm of
stressors, resulting in negative health consequences, particularly among underrepresented students who
persist in the face of adverse exposures. The proposed research aims to document 1) the role of specific
identity-related stressors in undermining the health of vulnerable groups as they pursue educational and
career advancement and 2) the role of social supports and resources in mitigating potential harm resulting
from marginalizing experiences. The proposed research will be conducted with a sample of 340 early adults
who previously participated in a five-wave longitudinal study across four years (96% retention rate). All
participants were recruited during their first year of college at an elite predominantly white institution and were
eligible to participate if they were a member of an underrepresented racial/ethnic group, a first generation
college student, or received the full amount of the Federal Pell Grant (i.e., demonstrated substantial financial
need). In the proposed research, established indicators of physical health and epigenetic aging will be
collected from this sample of young adults (ages 25-30) to assess how their previous and concurrent
experiences of marginalization (i.e., risk) and support (i.e., protection) may “get under the skin.” Biomarker
measurements will be utilized in order to identify health risk prior to disease onset. During early adulthood,
most chronic diseases are still asymptomatic and have not yet been detected via routine health screens. Thus,
the period of early adulthood allows for identification of prognostic indicators of future disease. Notably, the
proposed research aligns well with the scientific vision of the National Institute on Minority Health and Health
Disparities in that it aims to help explain disparities in disease by illuminating physiologic processes
resulting from social inequities. Additionally, the proposed research seeks to identify mechanisms of
resilience with attention to nuance across outcomes being studied (e.g., “skin-deep resilience”). A more
comprehensive understanding of risk and resilience processes and variability in how they play out among
marginalized groups can inform interventions to facilitate social mobility while also preserving and bolstering
the health of minority groups. Given that the emerging and early adulthood years hold great consequence for
the life course, interventions targeting this developmental period hold tremendous potential for reducing
health disparities, particularly health disparities that may be exacerbated counterintuitively by social mobility.

Public health relevance
PROJECT NARRATIVE The proposed research follows a sample of 340 underrepresented college students (ages 18-21) into early adulthood (ages 25-30) to examine 1) the prospective and cumulative consequences of marginalizing experiences during college and early adulthood on individuals’ physical health and aging processes and 2) the role of social supports and resources in countering or mitigating harm resulting from marginalizing experiences. The project has strong relevance to public health in that it aims to illuminate physiologic processes resulting from social inequities that help to explain disparities in diseases such as diabetes and cardiovascular disease. A more comprehensive understanding of risk and resilience processes and variability in how they play out among upwardly mobile marginalized groups will shed light on opportunities for interventions (e.g., trainings to reduce discrimination in predominantly white educational and employment settings, targeted programs to provide support to individuals facing marginalization) that hold the potential to facilitate social mobility while also preserving and bolstering the health of minority groups.